CANCER CENTER CORE SUPPORT GRANT

The Comprehensive Cancer Center at the University of Alabama in Birmingham conducts programs in immunobiology, immunogenetics, genetics and cell biology, RNA virology, DNA virology, molecular biology, experimental pathology, x-ray crystallography, NMR spectroscopy, tumor immunology, membranes, surgical oncology, radiation oncology, gynecologic oncology, medical oncology, pediatric oncology, nursing, biostatistics, and dentistry. It provides shared resources for immunosuppressed mice, NMR, x-ray crystallography, animal radiation, biostatistics, media preparation and tissue culture, histology, tissue procurement, and electron microscopy and proposes to develop a shared resource in fluorescence. It proposes to develop a program in epidemiology and the sequencing of proteins and nucleic acids, and to continue to support promising young investigators.